Administrative core

The administrative core will provide the organizational backbone for the overall proposal, coordinating the internal interactions between Projects and Cores as well as the external communication with NHLBI through the following specific aims: Specific Task 1: To facilitate communication between Projects 1-4 and Cores A and B and assist all projects in manuscript preparation. > Specific Task 2: To provide mechanisms for communication between UW, the Institute and project reviewers. Specific Task 3: To provide regulatory support to all projects and cores through interactions with the UW IRB and the FDA. The administrative core will interact with all projects and cores in this proposal through organization, notification and meeting minute distribution of monthly internal project review meetings. The administrative core will oversee the rate of subject accrual to assure that each project is able to meet its required sample size. The core will be responsible for preparation and submission of annual progress reports to the Institute and will organize external reviews as needed and the core will work with the FDA to obtain an Investigational New Drug application for the proposed use of anti-IL-5 antibody. The administrative core will assist all projects in collaborative manuscript preparation and preparation of slides for data presentations.